Optimization of Antibiotics in Mothers and their Breastfed Infants Using Pharmacomicrobiomic and Metabolomic Analyses (mPRINT P50)

PROJECT SUMMARY for MPRINT CET ADMINISTRATIVE CORE
The primary goal of the UCSD MPRINT CET is to serve as a national resource for knowledge and expertise in
maternal and pediatric pharmacology. The Multi-PI leadership of the UCSD MPRINT CET, who will lead three
Research Projects and two Support Cores (Milk Analytics and Pharmacometrics) excels in research fields of
maternal and infant health, human milk, antibiotic therapeutics, pharmacometrics, metabolomics and
microbiome. In order to successfully execute the goals of this program, we have formulated an Administrative
Core that will facilitate the research activities and provide timely and responsible oversight of the UCSD MPRINT
CET. The Specific Aims of the Administrative Core are: Aim 1: Provide leadership and oversight for the
UCSD MPRINT CET to maximize effective execution of the research program and achieve all deliverables
and milestones. The Administrative Core leadership (Drs. Tremoulet and Chambers) and program manager
(Kristin Woods) have exceptional track-records in administration of multisite networks and will coordinate
communication and overall cohesiveness among the various elements of the UCSD MPRINT CET and MPRINT
Hub. The Administrative Core will oversee the preparation of annual reports and publications, as well as handle
ongoing critical evaluation and outcomes assessment to achieve continual improvement of the MPRINT CET
effectiveness. In so doing the Administrative Core will optimize evaluation, reprioritization and adjustment of
activities, timelines and milestones. This Core will provide continuous and accurate financial management by
tracking the financial status of the UCSD MPRINT CET Projects, Cores, and Support Pool. Aim 2: Facilitate
the interactions of the UCSD MPRINT CET that will maximize the contributions to the MPRINT Hub The
Administrative Core leadership will identify emerging needs across the UCSD MPRINT CET to choose Support
Pool projects that will enhance the MPRINT Hub's role as a national resource in pediatric and maternal clinical
pharmacology. The Administrative Core will lead the effort to select the most meritorious and impactful Support
Pool projects. This Core will also be responsible for all communication with the MPRINT's Knowledge and
Research Coordination Center (KRCC) and support outreach and dissemination of new knowledge by
coordinating with the MPRINT KRCC's Outreach, Dissemination, and Training Core. Finally, the Administrative
Core will provide an integrated educational and practical mentored research training experience in maternal and
pediatric clinical pharmacology for health sciences professionals interested in becoming leaders in the field. In
achieving these aims, the Administrative Core will achieve its mission of fostering communication and
collaboration across the Research Projects and Cores at UCSD, as well as coordinate closely with the MPRINT
KRCC and the entire MPRINT Hub.